PHASE II TRIAL OF 9 AMINOCAMPTOTHECIN IN ADVANCED CUTANEOUS T CELL LYMPHOMA

This study is a phase II trial of 9-aminocamptothecin in advanced cutaneous T-Cell Lymphoma. To date 6 patients have been treated. Patient recruitment continues. This study is also enrolling patients at Northwestern.